Regulation of adipose tissue remodeling by the CCNC-Mediator

Project Summary/Abstract:
Obesity has become a major health problem. In contrast to pathologic obesity, “metabolically healthy
obesity” features less insulin resistance with more small adipocytes in subcutaneous adipose tissues. The
inability to increase the adipocyte number has been proposed as a cause of insulin resistance and type 2
diabetes in obesity. However, the regulatory mechanisms that control the number of adipocytes remain
enigmatic. Through functional screens, we have previously identified Cyclin C (CCNC) as a critical regulator
in brown adipogenesis. CCNC protein in mouse liver and brown fat is robustly downregulated in obesity or
aging. Relevant to human diseases, CCNC is significantly associated with body mass index (BMI) and type
2 diabetes in GWAS data, and the amino acid sequences of human, mouse, and rat CCNC are identical.
Using mouse models, we found that CCNC deletion at the whole-body level, or specifically in Ucp1+ cells or
hepatocytes enhanced cold-induced white adipose tissue (WAT) browning. Moreover, CCNC deletion in
hepatocytes resulted in a “metabolically healthy obesity” -like phenotype. These preliminary studies support
the role of CCNC in WAT remodeling and metabolic disease.
Although CCNC was historically named a “cyclin”, it does not directly regulate the cell cycle. Instead,
CCNC is the most conserved subunit of the Mediator complex, which is a multi-protein cofactor in gene
transcription. During transcription, the Mediator complex is recruited by activated transcription factors to
interact with the basal transcription machinery. As a result, the Mediator complex regulates transcription
highly depending on the gene of interest, cell type, and microenvironment of the cell. The central hypothesis
of this project is that in the context of the Mediator complex, CCNC regulates nutritional or environmental
cues-induced WAT remodeling through both WAT cell-autonomous and liver-WAT crosstalk mechanisms,
and the liver secretome can modulate the abundance of adipocyte progenitor cells (APCs). In addition to
our previous work, our hypothesis is supported by preliminary data from studying liver-specific knockout of
CCNC in mouse models, including reduced insulin resistance and increased subcutaneous adipocyte
number under high-fat diet, increased cell proliferation in subcutaneous WAT, and upregulation of hepatic
Pdgfa gene and elevation of PDGF-AA in blood. To test the hypothesis, we will pursue two Specific Aims.
Aim 1 will study the WAT cell-autonomous mechanisms and metabolic functions of enhanced WAT
browning upon CCNC deficiency. Aim 2 will study the cellular and molecular mechanisms for liver CCNC
regulation of WAT remodeling in mouse models of diet-induced obesity and cold exposure with a focus on
the role of liver-derived PDGF-AA.
A combined genetic and gene delivery approaches together with physiological, metabolic, histological,
biochemical, and molecular analyses will be used to carry out the proposed studies. All key animal models,
reagents, and techniques have been established, and key supporting data have been obtained. Successful
completion of these studies will yield novel insight into the role of the human BMI-associated CCNC surface
of the Mediator complex in regulating metabolism. Moreover, the experimental and conceptual models will
become a foundation of future studies on obesity. In the long run, we hope to identify new targets and/or
strategies for the prevention, diagnosis, and treatment of obesity and type 2 diabetes.

Public health relevance
Project Narrative (Public Health Relevance Statement) Gene expression is fundamental in biology. Defects in the regulation of gene expression cause various human diseases including obesity, insulin resistance, and type 2 diabetes. The Mediator complex is a key regulator for context-dependent gene expression. Using mouse models, we found that the conserved Mediator subunit Cyclin C (CCNC) plays an important role in regulating white adipose tissue (WAT) remodeling through cell-autonomous mechanisms or liver crosstalk with WAT. Further studies suggest that liver-derived PDGF-AA is a potential messenger for liver-WAT communication. Thus, this proposal will study the cellular and molecular mechanisms of how CCNC deficiency changes WAT upon environmental or nutritional challenges. The outcomes of this proposal will have significant and positive impacts in the field of obesity and metabolism by improving the understanding of WAT remodeling. These mechanistic studies will ultimately aid the development of new approaches for treating human metabolic diseases.